Mapping functional brain connectivity, neurodevelopment, and imaging-genetic associations in individuals with genetic and clinical risk factors for neuropsychiatric illness

PROJECT SUMMARY
In neurodevelopmental disorders such as schizophrenia (SCZ), genetic and environmental factors converge
on disrupted brain development and function. One way that we can gain more clarity on the relationships between
genes, neural systems, and symptoms is through considering rare genetic conditions with large effects on brain
development. 22q11.2 Deletion Syndrome (22qDel) is a recurrent copy number variant (CNV) in which a
hemizygous deletion of ~2.6 Mb of genetic material (~46 protein-coding genes) from chromosome 22 causes a
neurodevelopmental phenotype with a ~25% risk of psychotic illness and increased rates of ASD, intellectual
disability, attention deficit and anxiety disorders. Studying individuals with 22qDel can therefore provide an
impactful translational model and ‘genetics-first’ framework for understanding the complex biological pathways
underlying disabling conditions like SCZ. The proposed research plan seeks to map convergent and divergent
brain connectivity disruptions in 22qDel and in individuals at Clinical High Risk (CHR) for developing psychosis
spectrum disorders relative to typically developing (TD) controls. To this end, we will make use of the largest
multi-site sample collected to date of longitudinal resting-state fMRI from 22qDel (n=217) and matched controls
(n=149), along with data from the North American Prodrome Longitudinal Study (NAPLS) with CHR (n=318) and
TD (n=206). We will also apply spatial transcriptomic data from the Allen Human Brain Atlas (AHBA) to test
relationships between fMRI biomarkers and typical spatial patterns of gene expression in the brain. Specifically,
our aims are to: (i) Test the hypothesis that functional connectivity disruptions in individuals with genetic and
clinical risk factors for psychosis converge on brain-wide sensory and executive networks, (ii) Test the hypothesis
that 22qDel and CHR will exhibit convergent disruptions in functional connectivity development across the age
range relative to TD controls, and that individual deviations from typical trajectories will predict psychosis
symptoms, and (iii) Test the hypothesis that spatial patterns of resting-state fMRI disruptions in 22qDel are
related to spatial gradients of inhibitory and excitatory neuronal gene expression in post-mortem brain tissue
from typical adults. This multimodal approach aims to elucidate brain biomarkers and neurobiological
mechanisms related to genetic and clinical risk factors for psychosis spectrum disorders. To facilitate this
research, the proposed training plan includes coursework, workshops, and professional development activities
related to analysis of multi-site data, longitudinal data analysis, neurogenetics, and science communication. The
Bearden Lab and Neuroscience Interdepartmental Program at the University of California Los Angeles will
provide the ideal academic environment for the proposed training and research plan.

Public health relevance
PROJECT NARRATIVE Schizophrenia (SCZ) is a disabling neurodevelopmental disorder that generally emerges in adolescence or young adulthood due to the confluence of genetic and environmental risk factors. There is a critical need to characterize biological pathways underlying the development of SCZ and other neuropsychiatric disorders. Using longitudinal neuroimaging and spatial transcriptomics, this project aims to elucidate brain biomarkers and neurobiological mechanisms related to genetic and clinical risk factors for psychosis spectrum disorders.